Qualification of Drugs of Abuse and Related Substances in Biological Specimens

To provide a central research center for researchers in the field of drug abuse to reference. The new methodlogies shared can be assessed and validated .